The role of CDK6 in Alzheimer's Disease

Summary
Cellular senescence has recently emerged as a fundamental aging mechanism contributing to Alzheimer’s
Disease (AD). None of the numerous clinical trials to treat aging related diseases has been able to demonstrate
beneficial impact on patients. Moreover, the lack of a preclinical model of aging progression is a barrier to
therapeutic development. By using our Cdk6 mouse models and biochemical analyses, we have found that mice
lacking the CDK6 protein (KO) or its kinase domain (K43M) replicated many features of human aging. In contrast,
mice with constitutive kinase activity (R31C) had opposite phenotypes observed in KO/K43M mice. We have
also discovered senescent cells in the hippocampus and entorhinal cortex (EC) regions of KO/K43M brains but
not in those of WT/R31C brains at the age of 7 months. Although R31C mutation confers cells with constitutive
kinase activity, it does not enhance tumor susceptibility, which makes our proposed study more feasible.
Combined with other specific effects of CDK6 on
production of the
Neural Stem Cells (NSCs)6 and
antioxidants14,
induction of angiogenesis19, and mediating Notch1 signaling pathway which is involved in inhibition of Aβ5
production, all the evidence described leads us to hypothesize that CDK6 kinase activity is required for inhibiting
the development of AD, and therefore enhancing CDK6 kinase activity or targeting its effectors could be a novel
therapeutic intervention in the treatment of AD. The long-term goal of our studies is to validate CDK6 as an
attractive target for aging related AD, with the aim of identifying the novel therapeutic target genes regulated by
CDK6 in AD. The short-term goal of this proposal is to focus on central aims to define the cells attribute to
senescence (Aim 1) and to determine the molecular mechanism(s) whereby CDK6 affects senescence in the
defined senescent cells (Aim 2). Guided by solid preliminary data, the central hypothesis will be tested in two
specific Aims: (Aim1) Defining the cells which attributed to the senescence in hippocampus and EC by flow
cytometry, immunohistochemistry, RT-PCR, and Western Blotting. (Aim 2a): Determining the requirement of
CDK6 for self-renewal and differentiation of the NSCs by isolating undifferentiated NSCs positive for Nestin and
Sox-2 and then by performing self-renewal and differentiation assays as described8,9. Quantification of expressed
markers will be determined by Flow cytometry analysis, Western Blotting, and immunohistochemistry; (Aim 2b):
Determining the cell autonomous effect of CDK6 on senescence by re-expression of CDK6 specifically on the
defined senescent cells to observe if re-expression of CDK6 can reverse the senescence observed in KO brain;
(Aim 2c): Determining if loss of CDK6 kinase activity in mice may trigger oxidative stress and the inflammatory
cascades known to induce neuroinflammation. Overall, the proposed studies will generate adequate data to
support the design and initiation of experimental approaches designed for the next phase.

Public health relevance
Project Narrative Cellular senescence has emerged as a fundamental aging mechanism for Alzheimer’s Disease (AD), a debilitating condition without viable options for treatment. Moreover, the lack of a preclinical model of aging progression is a barrier to therapeutic development. By using novel and physiologically relevant Cdk6 mutant mice, we showed that mice with dead protein were aging faster, while mice with hyper-active protein are aging slower than normal mice, forecasting a highly attractive and potentially novel pharmacological intervention in the treatment of AD by targeting CDK6 or its effectors.